Using Single Cell Biological Approaches to Understand CNS TB

PROJECT SUMMARY
Tuberculosis is a global disease affecting millions of people in primarily developing regions of the world. Central
nervous system tuberculosis (CNS-TB) is the most severe extra pulmonary form of the disease, which, despite
aggressive therapeutic intervention, can have a fatality rate of up to 80%. Significant barriers to understanding
disease pathogenesis exist, which translates to poor diagnosis and treatment outcomes. Thus, improved insight
into neuro-glial-immune cell interactions in CNS TB, and the factors that regulate brain pathology require a global
molecular and cellular perspective. Our long-term goal is to understand the mechanisms associated with
the development of CNS-TB, and different CNS-TB outcomes, in order to develop novel, effective, and
broadly accessible therapeutics. Single cell/nucleus RNA sequencing (sc/snRNA-seq) gene expression
analysis allows for a large-scale view of the cells and molecular pathways involved in neuropathogenesis, with
the potential to identify novel differences between TB diseased states. In this study, we will investigate
transcriptional changes induced by M. tuberculosis infection of the brain under clinical and experimental
conditions to determine how CNS-TB starts and progresses to different outcomes. This is made possible by
preliminary snRNA-seq data generated during our Global Brain R21 that we recently completed. We hypothesize
that M. tuberculosis invades the CNS due to the failed generation of an appropriate neuroimmune response in
CNS resident and peripherally recruited immune cells. This is strongly supported by our preliminary data from
human and rodent snRNA-seq studies. By exploring the transcriptional differences in cells from normal and
diseased states we will be able to identify the cell type-specific molecular and cellular processes that underpin
the pathogenesis of CNS-TB, including neuroinflammation and immune system engagement. Understanding
cell type-specific CNS and immune signaling in CNS-TB will enable us to develop novel therapies and
improve clinical outcomes. To test our central hypothesis, we will determine the molecular pathways across
CNS and immune cells that define clinical phenotypes in patients with CNS-TB and create a full disease spectrum
signaling framework of CNS-TB using multiple mouse models. In addition to our scientific aims, we will expand
the single cell gene expression analysis platform, established at the University of Cape Town (UCT) during our
Global Brain R21 support, to the broader African scientific community. We aim to provide training in project
planning, library preparation, and data analysis. When complete, we will have a novel understanding of the
cell type-specific inflammatory signaling events that drive CNS-TB and will be poised to engage novel
molecular targets to improve CNS-TB outcomes. Furthermore, UCT will be established as a hub of single
cell biology, to launch scientific careers of the next generation of African scientists, and to improve
health care across Africa.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) can lead to severe neurological dysfunction when infection spreads to the CNS (CNS-TB) and is the cause of significant neurological complications around the world. Here we will use single cell and single nuclei RNA-sequencing of human brain and CSF samples from patients with CNS-TB, along with a spectrum of rodent models that represent different severities of CNS-TB, to determine how different cell types contribute to human CNS-TB. We will work to build single cell/single nuclei RNA-seq research capacity at the University of Cape Town by developing research infrastructure in South Africa and facilitating skills transfer through a structured training and skills development program.